Coordinate Regulation of Virulence in Vibrio Cholerae

Modified Project Summary/Abstract Section

Vibrio cholerae remains a major threat to world health in that cholera epidemics have ravaged Yemin, Africa, South Asia, and Haiti in only the last decade. This bacterial organism is also a powerful model system for understanding microbial pathogenesis and has ushered many new technologies for analyzing pathogen-host interactions. This proposal seeks a deeper understanding of how this mucosal pathogen interacts with commensal organisms, viral agents, and the host immune system. AI-018045 has previously supported V. cholerae research that has led to the discovery and characterization of cGAMP, a cyclic dinucleotide (CDN) and isomer of the product produced by cGAS (an immune sensor of clinical importance to autoimmunity and cancer). V. cholerae was used to engineer a form of the human cGAS enzyme that is locked in a DNA-bound, active conformation and this allowed its crystal structure to be solved facilitating anti-cGAS drug discovery. Previously, killing by the V. cholerae Type VI secretion system (T6SS) of commensal E. coli strains was found to induce an innate immune response that triggered early V. cholerae virulence gene expression in the host. The present proposal now offers creative experimental approaches aimed at new challenges that have emerged from these discoveries including 1) understanding the biological activities of cGAMP made by the V. cholerae enzyme DncV including phage resistance and whether other novel cyclic and linear oligonucleotides synthesized by DncV-related enzymes discovered in the genomes of thousands of bacterial isolates have immunomodulatory activity and anti-viral function, 2) testing the hypothesis that cholera toxin (CT) production drives transmission through diarrhea or by reprogramming host metabolism so V. cholerae can take advantage of a CT-induced niche that is rich in hemin and long chain fatty acids, 3) understanding host innate immune activation that depends on the attack of commensal organisms by the T6SS of V. cholerae and 4) continuing the development of live attenuated probiotic-like vaccine HaitiV and Whole Cell Conjugate (WCC) vaccine technologies. State-of-the-art genetic, biochemical and cell biological approaches will be employed to address these topics which offer answers to questions such as i) what are the most important T6SS effectors and host pathways involved in T6SS commensal killing and induction of intestinal colonization by V. cholerae HaitiV? ii) Would commensal, pathogenic, or attenuated organisms loaded with CDNs enhance T6SS-dependent host innate signaling and intestinal colonization of HaitiV? iii) Can a CRISPRi gene silencing technology developed for V. cholerae be used to enhance production of outer membrane vesicles which might deliver cGAMP or bacterial effector proteins into host cells? This proposal offers scientific impact that extends well beyond addressing cholera as a threat, and is likely to yield new discoveries that will reshape microbiological research in important areas of unmet medical need including antimicrobial vaccinology, immunomodulation, the host response to commensal microbiota, adjuvant research and drug development.

Public health relevance
Modified Specific Aims Section Work supported by AI-018045 has been transformative in the field of microbiology through innovations that have fueled discovery beyond its primary focus - Vibrio cholerae. The present application seeks to continue this success through four Specific Aims. While different, these research lines are bridged by the tools available in the V. cholerae system that include strong bacterial genetics, animal models of infection, molecular insights into the role of microbial antagonism in infection biology, and the ability to develop and test innovative ideas in vaccinology. Proposed studies also seek discoveries that has exciting translational potential in immunology. SPECIFIC AIM #1. To understand the biological activities of 3'3' cGAMP made by DncV and other novel cyclic and linear oligonucleotides synthesized by D-NTase superfamily members. The novel cyclic di-nucleotide (CDN) synthesized by the V. cholerae 7th Pandemic Island gene product DncV (3'3' cGAMP) is now recognized to be an isomer of the CDN made by the human innate immune response enzyme cGAS. Mutants characterized in V. cholerae has led to the determination of the crystal structure of activated human cGAS (reported recently in Cell). This award has also supported the characterization of DncV-like nucleotidyltransferase (D-NTase) enzymes that include many which synthesize novel cyclic di- and tri-and linear oligonucleotides. We propose to explore the activity of DncV and other D-NTases in cell biological processes such as viral resistance and signal transduction in the V. cholerae system where phenotypes and genetic suppression analysis can be fully leveraged. We will seek answers to questions including: A. How does DncV over-expression in V. cholerae cause phage replication defects? B. Are other genes involved in DncV-mediated phage resistance including a VSP-1 encoded lipase that is modulated by 3'3' cGAMP, as well as gene products with similarities E1/E2-like ubiquitin ligases and deubiquitinating peptidases? We will test the hypothesis that these DncV-related pathways encode in vivo phage resistance which alters the replication and transmission of V. cholerae especially in the presence of ongoing phage infection within the animal host. SPECIFIC AIM #2. To test the hypothesis that CT production drives transmission through multiple in vivo induced phenotypes. We have observed that transmission of V. cholerae between infected and uninfected rabbit pups within the same litter depends on the ctx locus which encodes cholera toxin (CT). CT causes changes in V. cholerae gene expression patterns in vivo that suggest that a host environment that is depleted in iron and enriched in long chain fatty acid (LCFA) as a direct consequence of CT's action on the intestinal mucosa. Therefore we will address the following two questions: A. Does CT act directly or indirectly to stimulate transmission of V. cholerae? B. Do CT-dependent changes in V. cholerae in vivo metabolism drive V. cholerae transmission and does the CDN 3'3' cGAMP play a role in transmission as well as enhancing intestinal colonization through its effects on for example chemotaxis and phage restriction. SPECIFIC AIM #3. To understand host cell signaling that depends on the attack of commensal organisms or enteric pathogens by the T6SS of V. cholerae. This year in Science we provided evidence that T6SS-dependent killing of commensal E. coli strains triggers a more robust host innate immune response and induction of the ToxT regulon (the 'T6SS commensal effect'). Therefore, we propose to follow-up these exciting results to answer the following questions: A. Can we identify the most important T6SS effectors and host pathways involved in the T6SS commensal effect? B. Would commensal or pathogenic organisms (such as ETEC) loaded with CDNs or not, enhance T6SS-dependent host innate signaling and ToxT activation in vivo? In the latter case, we will also take advantage of CRISPRi technology for V. cholerae that has revealed fascinating cell biological effects including enhanced production of outer membrane (OM) vesicles when lipoprotein biogenesis is impaired. C. We propose to test if these vesicles are loaded with DCNs and if such vesicles can deliver them to host cells and if the VSP-1 cGAMP-activated lipase enhances this effect. SPECIFIC AIM #4. To continue the development of live attenuated probiotic-like vaccine HaitiV and Whole Cell Conjugate (WCC) vaccine technology. We have collaborated on the development of a new live, attenuated V. cholerae 'probiotic-like vaccine' called HaitiV that engenders rapid protection against V. cholerae in less than 24 hr. We plan to improve HaitiV by engineering antagonistic heterologous T6SS effectors that are directed against wt V. cholerae. These effectors will likely release innate immune activating ligands from prey cells and together with CDNs could enhance HaitiV's probiotic-like activity and immunogenicity. We have also developed a new approach to making potentially better killed cholera vaccines called Whole Cell Conjugate (WCC) vaccine technology. We will test WCC immunogens prepared from formalin fixed V. cholerae O1 and O139 cells and measure the serum vibriocidal antibody levels they induce in neonatal animals. We will explore if loading of killed bacterial cells with DCNs enhances their immunogenicity. These studies could provide a new exciting vaccine platform for mucosal immunization and potentially immunomodulation as well.